Mannose metabolism as a regulator of hepatic stellate cell activation and fibrosis

PROJECT SUMMARY
This proposal addresses the critical unmet need for effective anti-fibrotic therapies by elucidating an unexplored
pathway regulating activation of the hepatic stellate cell (HSC), a resident perisinusoidal cell type that stores
vitamin A in normal liver. However, among potential mechanisms driving HSC plasticity, sugar
metabolism
pathways have been largely overlooked. The role of mannose metabolism in HSC biology has not yet been
examined, but recent high-impact studies, including ours (Shtraizent and DeRossi et al., eLife 2017), implicate
mannose as a mediator of obesity, diabetes, and cancer. Mannose phosphate isomerase (MPI) is the key
enzyme involved in catabolism of mannose; MPI
glycosylation
mutation in humans leads to a congenital disorder of N-
characterized by early and progressive liver fibrosis in children. Our data and these clinical
observations stimulated us to explore how the loss of MPI in this pediatric disorder leads to liver fibrosis. Our
exciting data find that: 1) MPI expression is downregulated during HSC activation in primary human and rodent
HSCs in vitro and in vivo, 2) decreased MPI correlates with advanced stages of liver fibrosis in human HBV and
NAFLD cohorts, and 3) MPI depletion promotes HSC activation in human HSCs. Remarkably, mannose
supplementation attenuates HSC activation in a dose-dependent manner. Our objective is to understand the
regulatory role of mannose metabolism in HSCs and liver fibrosis. With the following aims, we will test our
central hypotheses that mannose metabolism is a critical metabolic pathway mediating HSC activation
and attenuation. Disruption of mannose metabolism, through loss of MPI, leads to HSC activation;
conversely, exogeneous mannose supplementation can attenuate HSC activation and liver fibrosis in
vivo. Specific Aims: Aim 1. Determine how MPI loss activates HSCs: By using primary rat HSCs and in vivo
genetic zebrafish models, we will investigate the role of O-GlcNAcylation in HSC activation, determine the cell-
specific effects of MPI-depletion, and test whether enhancing MPI activity can attenuate fibrogenesis following
exposure to well-established HSC activators. Aim 2. Determine the efficacy of mannose supplementation in
attenuating HSC activation in vitro and in vivo. This aim will use in vivo rodent models of fibrosis to investigate
how mannose supplementation modulates the plasticity of HSC phenotypes and test the extent of mannose to
attenuate liver fibrosis in vivo. Our long-term goal is to better understand the metabolic drivers of HSC activation
to manipulate these fuel-generating mechanisms and attenuate liver fibrosis. We
the
and
are
will leverage our expertise in
biology of a rare liver disease to advance our understanding of the metabolic regulation of HSC activation,
to establish how this overlooked pathway of mannose metabolism can regulate HSC plasticity. These studies
the first to investigate the antifibrotic roles of mannose supplementation andmay reveal a novel target and
accessible therapeutic approach to suppress liver fibrosis.

Public health relevance
PROJECT NARRATIVE Chronic liver disease can lead to irreversible scarring of the liver, which can lead to liver failure, liver cancer, and necessitate liver transplantation. Currently, there are no approved medical treatments to effectively reverse scarring. This project proposes to investigate a new pathway involved in liver scar formation that can potentially lead to new drug targets.